2024 HOPE Summit

1 Experiences, both positive and negative, affect health outcomes. Adverse childhood
2 experiences (ACEs) are linked to poor adult mental and physical health. Positive childhood
3 experiences (PCEs) can mitigate the effects of ACEs and toxic stress. The HOPE framework
4 groups PCEs into four fundamental building blocks: relationships with adults and other children;
5 safe, stable and equitable environments to live, learn and play; social/civic engagement; and
6 opportunities for social/emotional development. Implementation of the HOPE framework
7 promotes a relationship-based approach which transforms interactions between providers and
8 parents, focuses on a family’s assets and strengths, and upholds family agency and expertise,
9 leading to an alignment of the family’s and practitioner’s goals. Launched in 2019, the HOPE
10 National Resource Center (NRC) supports national adoption of the HOPE framework in clinical
11 and community-based settings through training, technical assistance, translational research,
12 and evaluation. Dissemination has been successful, exceeding our internal targets. Our annual
13 summit strategies power the diffusion of innovation model. Our 2021 national summit, focused
14 on increasing awareness and understanding of the HOPE framework. Our second summit,
15 supported by an R13 award from the National Institute of Child Health and Human Development
16 (NICHD), centered on Growing HOPE, and highlighted community resilience. The 2023 NICHD
17 supported Summit, Practicing HOPE, focused on early adopters of HOPE-informed care.
18 Evaluation feedback from the 2023 Summit indicated a desire for more opportunities for
19 networking, and for in-person meetings. With NICHD support we will work with partner
20 organizations in Massachusetts, California and Tennessee to hold three, local in-person satellite
21 meetings in April, May and June of 2024 following our 2024 Summit. These tailored satellite
22 meetings will focus on HOPE organizational transformation. Applying the Consolidated
23 Framework for Advancing Implementation (CFIR) model, our previous summits have focused on
24 the inner setting, reaching out to individuals involved in direct service and in local decision-
25 making. This proposal will focus on the outer setting domain of the CFIR to promote the
26 widespread implementation of the HOPE framework in an organizational setting, by supporting
27 satellite meetings to foster the emerging implementation climate with discussions that identify
28 and address specific implementation barriers and facilitators. The goal of the HOPE Satellite
29 Meetings is to catalyze and support organizational transformation and adoption of HOPE.

Public health relevance
Positive childhood experiences prevent and mitigate the effects of adverse childhood experiences and lead to improved adult health outcomes. The HOPE framework is a relationship-based approach which transforms interactions between providers and parents, opening up dialogue to focus on a family’s assets and strengths, bringing in family agency and ultimately leading to an alignment of the agency’s goals and family’s priorities. The goal of the HOPE Regional Satellite Meetings is to catalyze and support organizational transformation and adoption of HOPE.